Dissection of SARM1-Induced Axon Degeneration and Cell Death

Project Summary/Abstract
Programmed axon degeneration (AxD), a.k.a. Wallerian degeneration, is a genetically encoded cellular
program akin to apoptosis by which neurons effect the orderly demolition of diseased or damaged axons. Our
prior work demonstrated that the chief executioner of AxD, SARM1, is an NAD+ hydrolase allosterically regulated
by NAD+ and its precursor NMN. SARM1 activation causes depletion of NAD+ that leads to local metabolic
catastrophe and axon dissolution. SARM1-dependent AxD was primarily elucidated in models of acute injury that
trigger all-or-none rapid axon loss, but we and others have also identified diverse conditions that provoke chronic
SARM1 activation below the threshold necessary to provoke rapid AxD. Such subliminal SARM1 activity likely
contributes to common neurodegenerative diseases including ALS, CMT2A and diabetic neuropathy. Our
evidence indicates that this activity involves upstream and downstream molecular mechanisms that may not be
engaged during canonical axotomy-induced Wallerian degeneration, mechanisms that impair axon resilience
and contribute to compromised axon integrity and function in progressive neurodegenerative disorders. To
enable the study of this subliminal SARM1 activity, we developed means to both manipulate and monitor the
AxD pathway via titrating SARM1 activation and quantitatively measuring cADPR, a SARM1 activity biomarker.
Here we use these tools to investigate the regulation of SARM1 by post-translational modification and the
mechanisms by which DNA damage induces SARM1-dependent AxD. Our preliminary data show that SARM1
binds to and is ubiquitinated by Parkin in response to mitochondrial damage. We propose experiments to
determine the unexplored impact of K63 regulatory ubiquitination on SARM1 activity. Such regulatory events are
likely to impact chronic SARM1 activation and progressive disease. We will use kinase inhibitor panels to identify
novel SARM1 regulators and employ a fluorescent SARM1 activity sensor and imaging-based screening
technologies we recently developed to identify molecular components regulating SARM1 function by performing
a CRISPR screen in models of subliminal SARM1 activation using gRNAs targeting all druggable genes including
most kinases. We also find that disrupted cellular DNA repair activates SARM1-dependent AxD. DNA damage
is associated with peripheral neuropathy in many neurodegenerative diseases including ALS and rare genetic
disorders, as well as after chemotherapy. We will define the mechanisms of SARM1 activation due to DNA
damage and how SARM1 promotes DNA damage-induced degeneration using human motor neuron models of
ALS. Finally, our previous work led directly to development of therapeutic SARM1 inhibitors that are now in
clinical development. Here we propose to develop therapeutic SARM1 activators as axon-specific neurolytics to
treat localized chronic pain. In total, these studies will define mechanisms that regulate subliminal SARM1
activation relevant to chronic disease, identify alternative therapeutic targets for neurodegenerative disorders,
and directly generate novel non-opioid medicines to treat pain.

Public health relevance
Project Narrative Diverse factors contribute to neurodegenerative disease, but many of these converge on SARM1, an enzyme that regulates the maintenance of axons, the nerve cell appendages used to communicate to other cells. The regulation of SARM1 activity is complex and can be affected by DNA damage, which is associated with many neurological disorders as well as chemotherapy. Here we investigate SARM1 regulation and the development of a neurolytic non-opioid treatment for pain based on targeted SARM1 activation.